CAP - Consortium to Alleviate PTSD - STVHCS Project 7

Project #7 - Randomized Clinical Trial of Cognitive-Behavior Therapy for Posttraumatic The purpose of this study is to establish the first basis of evidence for a manualized behavioral management protocol for PTHA. The primary study objective is to evaluate the effectiveness of a non-medication, clinic-based cognitive-behavioral intervention (CBT) for service members with PTHA who have experienced a blast-related traumatic event resulting in PTSD and mTBI symptoms. Aim 1: To conduct a 3-group randomized clinical trial of the efficacy of (1) clinic-based cognitive- behavioral therapy (CCBT); (2) minimal therapist-contact cognitive-behavioral therapy (MCCBT); and (3) a 6-week therapist monitored (TM) control condition for treatment of chronic posttraumatic headache within active-duty military personal and veterans. Aim 2: To evaluate the relationship of post-concussive cognitive symptoms and posttraumatic stress symptoms to primary treatment outcomes. Aim 3 (Exploratory): To examine the contribution of biomarker and imaging data to illuminate factors that contribute to PTHA chronicity and treatment response.

Public health relevance
The STRONG STAR Consortium to Alleviate PTSD Project Narrative The overarching goals of STRONG STAR-CAP are to improve the psychological and physical health and well-being of Service Members (Active Duty, National Guard, and Reserve) and Veterans who have deployed in support of OEF/OIF/OND by developing and evaluating the most effective diagnostic, prognostic, preventive, treatment, and rehabilitative strategies for combat-related PTSD and comorbid conditions. STRONG STAR, the NCPTSD, and other VA investigators will leverage our already-established facilities, infrastructure, relationships, and funding to ensure the success of STRONG STAR-CAP.